The role of mitochondrial regulation in cell lineage specification and function

ABSTRACT
The role of mitochondrial regulation in cell lineage specification and function
During cell lineage specification, metabolic reprogramming, together with transcriptional and epigenetic
modifications in the progenitor cells are integral parts of cellular adaptations to the cell fate instructive cues.
When this process goes awry, developmental defects as well as malignancies will occur. Common in all the
cellular systems, mitochondria are bioenergetic, biosynthetic and signaling organelles central to metabolic
remodeling. Understanding mechanisms of mitochondrial function during lineage specification will be critical for
therapeutic normalization of derailed cellular metabolism and functions in pathogenesis. Though mitochondrial
regulation is still unclear, our published and preliminary work revealed critical roles of mitochondrial
metabolism and mitochondrial dynamics during cell lineage specification. Furthermore, differentiated cells
continue to receive low-level, constitutive signaling in the basal state (“tonic signals”), important for cell survival
or functions. Our research suggested that mitochondrial regulation is actively maintained in mature
differentiated cells downstream of tonic signals and revealed potential new regulators for this process. The
overarching theme of our research is to unravel the diverse mitochondria mediated mechanisms regulating cell
lineage differentiation and homeostatic functions. In Project 1, we will use high resolution imaging to
characterize distinct mitochondrial morphology, and dynamic events in live cells. Using genetic tools, and an
organ culture system to model cell lineage specification, we will decipher the role of mitochondrial dynamics in
metabolic remodeling during differentiation. In Project 2, using a sophisticated system of transferring cells into
environments with defined levels of tonic signals, we will assess the alterations in mitochondrial dynamics and
functions in the presence and absence of tonic signals. Through pharmacological means or genetic
modifications such as CRISPR/Ca9 in differentiated cells, we will determine the causal relationship between
mitochondrial regulation and maintenance of cellular functions. Upon completion of our work, we will have
uncovered the versatile mechanisms by which mitochondria influence lineage specification and homeostatic
functions.

Public health relevance
NARRATIVE – PUBLIC HEALTH RELEVANCE STATEMENT Mitochondria are essential organelles in all eukaryotic cells, and their dysfunction has severe consequences in development and diseases. Mitochondria are highly dynamic through biogenesis, trafficking, changing morphology and targeted removal. Our research seeks fundamental understanding of the regulatory biology of mitochondria under normal physiology focusing on the crosstalk among mitochondrial dynamics, mitochondrial functions, cellular metabolism and signaling.